Peripheral blood mononuclear cell epigenetic associations in and biomarkers for knee osteoarthritis development and progression

Project Summary / Abstract
The objective of the proposed research is to better understand how peripheral blood immune cell composition
and/or epigenetic patterns change during knee osteoarthritis (OA) development and progression. Our laboratory
has previously examined in detail the biomarker potential of peripheral blood epigenetic changes both to predict
future rapid radiographic/pain progression in patients who already have early knee OA, as well as to detect
preclinical OA (e.g. patients who do not have radiographic OA but will develop it in the near future). In the current
study, we will expand upon these findings both to generate higher-resolution epigenetic maps of peripheral blood
as well as to determine epigenetic changes within individual immune cell subsets. Our first Aim is to perform
high-resolution sequencing-based 5-methylcytosine (5mC) and 5-hydroxymethylcytosine (5hmC) analysis on OA
patients from across the disease spectrum. Our second Aim is to determine epigenetic changes (and correlated
gene transcription changes) within individual immune cell subsets using an innovative paired single-cell RNA-
seq and ATAC-seq analysis pipeline and compare these findings with those of Aim 1. Our third Aim is to develop
a novel set of high-resolution DNA methylation array-based peripheral blood composition models using scRNA-
seq data from Aim 2 and additional data already generated by our institution, and then to apply these models to
our previously-generated large OA peripheral blood DNA methylation datasets, thereby enabling the detection
of small changes in immune cell subsets in various OA patient endotypes. The proposed work is important,
as we do not have a full understanding of how the systemic immune system influence OA risk, nor do we have
robust clincally-available biomarkers to distinguish future OA progressors or detect preclinical disease. Our work
is quite innovative in its hypotheses as well as the use of cutting-edge deep single-cell and deep sequencing
epigenetic analysis and use of machine learning methods to develop discriminatory models. Success in our
proposal may open a new avenue for OA inflammation research and may offer a novel treatment strategy for
OA.

Public health relevance
Project Narrative The proposed research is relevant to public health because a better understanding of how peripheral blood immunophenotype changes increase the risk for osteoarthritis (OA) and/or the development of epigenetic-based predictive models for OA clinical care is likely not only to give insights into the causes of OA, but also to give rise to new treatments for OA patients. Thus, this proposal is relevant to the part of the NIH's mission that pertains to fostering fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately improving health.